The impact of ultra-low oxygen IVF on preimplantation and postnatal development

PROJECT SUMMARY
Assisted Reproductive Technologies (ART) are non-coital methods of achieving a pregnancy, and most often
involve the manipulation of gametes or embryos. Importantly, the use of ART is increasing as they become
more accessible and more couples experience infertility or postpone childbearing. In vitro fertilization (IVF) is
one of the most common ART used in clinics today, in which eggs are combined with sperm and cultured until
the blastocyst stage before transfer to a recipient female. Although beneficial and safe, IVF procedures have
been associated with suboptimal outcomes for mother and baby including pre-eclampsia, fetal and placental
growth abnormalities, an increased rate of rare imprinting disorders, and dysregulated postnatal metabolism.
Indeed, human IVF children experience elevated body weight, glucose intolerance, and insulin resistance
beginning in adolescence. These outcomes may result from IVF procedures, especially embryo culture, which
exposes a developing embryo to altered environmental conditions not normally experienced in vivo during a
time in which the epigenome must be reprogrammed for proper development. One important environmental
factor during embryonic development is oxygen (O2), which can influence gene expression, metabolism, and
the activity of important epigenetic enzymes. Today, the lowest O2 tension used during embryo culture is 5%,
despite evidence that sections of the mammalian female reproductive tract have O2 levels as low as 2%. Thus,
decreased O2 tension during embryo culture may better mimic the in vivo environment, leading to improved
pre- and postnatal outcomes in the offspring. Consistently, preliminary studies from my thesis lab have
demonstrated that culture at 2% O2 improves blastocyst morphology, molecular signatures in embryonic liver,
and placental outcomes compared to culture at 5% O2. Given that culture at 2% O2 improves some offspring
outcomes, I hypothesize that the molecular profiles of embryos cultured at 2% O2 will more closely
resemble naturally-conceived embryos (Naturals). Additionally, I hypothesize adult IVF offspring after
2% O2 culture (IVF 2%) will display less severe metabolic outcomes compared to 5% O2 culture (IVF
5%) IVF offspring. To test these important hypotheses, I will use our validated IVF mouse model, which
recapitulates many of the phenotypes observed after IVF in humans. In Aim 1, I will explore how culture under
difference oxygen tensions (2 vs. 5%) impacts gene expression, DNA methylation, and histone
posttranslational modifications in blastocysts. In Aim 2 I will determine if metabolic outcomes in adult IVF
offspring are improved after culture at 2% O2, and whether this improvement translates to the transcriptome
and methylome of the liver. This project will determine how embryo culture at 2% O2 impacts both
preimplantation development and adult metabolic health outcomes. Overall, this research will contribute
foundational insights to our understanding of the role of O2 in early development, with key implications for
clinical IVF practices.

Public health relevance
PROJECT NARRATIVE The use of assisted reproductive technologies is increasing worldwide, and although beneficial, they have been associated with suboptimal outcomes for both mother and baby. The oxygen tension in which embryos are cultured has consequences for proper development, and preliminary data from our lab suggests an ultra- low oxygen tension may improve preimplantation and pregnancy outcomes after IVF. This proposal will investigate the impact of ultra-low oxygen tension during embryo culture and its potential to significantly improve the clinical practice of IVF.